Local Flavor Policies to Enhance Equity in Tobacco

ABSTRACT
Policies restricting the sale of flavored tobacco products (FTP) are being enacted in localities around the US.
We seek to expand the evidence base about the extent to which these policies decrease access to FTPs and
exposure to flavored tobacco marketing and would likely reduce use of tobacco among youth and young adults.
Additionally, few studies examine the potential of these policies to reduce tobacco-related health disparities
among youth/young adult populations of color and those of lower socioeconomic status (SES). These vulnerable
populations use flavored products at higher rates and FTPs are heavily marketed in communities where these
vulnerable groups live. Determining the impact of FTP policies overall and on populations of color and lower SES
youth/young adults in these communities can make sure that policies are structured to ensure equitable reach
and reduce tobacco use disparities. The purpose of this study is to determine the impact of flavor policies on
reducing exposure to and use of FTPs among vulnerable youth/young adults. Using the Policy Implementation
Framework and the Elaboration Likelihood Model as our theoretical guides, we combine national, local and
individual data to examine the equity impact of flavor policies around the US. To accomplish the study purpose
we will conduct several aims. (1) We will use a longitudinal national dataset of youth and young adults (n=13,892)
followed for nine waves twice a year from 2014 to examine changes in tobacco marketing exposure and FTP
and non-FTP use in those exposed to an FTP policy with no FTP policy exposure over time, focusing on
differences by race/ethnicity and SES. (2) We will compare marketing exposure to and appeal of FTP/non-FTPs
between emerging adults in communities covered by flavor policy variants through ecological momentary
assessment (EMA), evaluating differences in outcomes by SES and race/ethnicity at the individual and
neighborhood level. (3) Finally, among EMA participants, we will assess the predictive validity of exposure to
FTP/non-FTP marketing exposure on use of FTP and non-FTPs at 6-month follow-up, and evaluate whether
these outcomes are associated with SES and race/ethnicity. For all of these activities, we will partner with
national and local FTP policy experts who will disseminate lessons learned to communities who have or are
considering an FTP policy. Achieving the aims of this R01 will expand the evidence base of the impacts of FTP
policies on reducing tobacco use and potential equity impact of these policies to reduce tobacco, and ultimately
cancer disparities.

Public health relevance
PROJECT NARRATIVE This project seeks to examine whether innovative local tobacco control policies restricting sales of flavored tobacco products can reduce tobacco use and disparities in tobacco and, ultimately cancer. The study will examine trajectories of flavored tobacco use in a large longitudinal national cohort of youth and young adults among those exposed and not exposed to policy. It will also examine youth and young adult non-tobacco user exposure to tobacco marketing and subsequent tobacco use outcomes in real-time in eight communities with different flavor policy variants and will have a particular focus on assessing differences in policy impact across vulnerable group status.